Molecular mechanisms of ribosome biogenesis by force-producing enzymes

PROJECT SUMMARY
Ribosomes are molecular machines made of protein and RNA that synthesize proteins. The biogenesis of new
ribosomes is amongst the most energetically costly processes in the cell, accounting for ~60% of all ATP
consumed. Ribosome biogenesis is dysregulated in a series of diseases known as ribosomopathies, and
upregulated in proliferative cancers. However, the molecular mechanisms underlying ribosome biogenesis – how
ATP-driven mechanoenzymes (force-producing enzymes) sequentially convert ribosomal precursors into mature
particles – remain poorly understood. The knowledge gap is especially prominent in human systems, as most
studies on ribosome biogenesis to date have focused on yeast model systems using top-down approaches. The
overall vision for my research program is to fill this gap in knowledge; to mechanistically characterize the
enzymology of human ribosome biogenesis, to reconstitute ribosome biogenesis steps in vitro, and to integrate
the knowledge and assays developed to enable new treatments for ribosomopathies and cancer. Over the next
five years, we will focus on the subset of mechanoenzymes from the AAA (ATPase associated with diverse
cellular activities) superfamily. Building upon our expertise in single-molecule optical tweezers, we will develop
assays to determine how these mechanoenzymes use ATP-dependent conformational changes to generate
force. Using bottom-up biochemical reconstitution, we will determine how autoinhibited AAA mechanoenzymes
become activated by cofactor binding, how AAA activity is targeted at specific pre-ribosomal substrates, and how
force-producing conformational changes are coupled to pre-ribosomal maturation. We will furthermore use small
molecule inhibitors of these AAA enzymes to stabilize transient conformational states and to identify how the
several ATPase active sites present per molecule coordinate their activities. Initial assays will use yeast AAA
orthologs, before advancing to the human orthologs to study how AAA cofactors unique to the human system
integrate into the overall mechanisms. We will also study how ribosomopathy-associated mutations in human
AAA enzymes affect their function. Ultimately, this work will characterize the core enzymology of AAA-driven
ribosome biogenesis steps, will build a molecular understanding of associated ribosomopathies, and will pave
the way towards developing AAA-targeting anti-cancer therapeutics.

Public health relevance
PROJECT NARRATIVE The production of new ribosomes – macromolecular machines that make proteins – is driven by force-producing enzymes. Abnormal ribosome production is strongly linked to aggressive cancers as well as a set of genetic diseases known as ribosomopathies. The goal of this proposal is to characterize the molecular mechanisms of ribosome biogenesis by force-producing enzymes – to discover core biology, to characterize ribosomopathies, and to pave the way towards anticancer therapeutics that target ribosome biogenesis.